Predictive multi-scale model of focal adhesion-based durotaxis

Project Summary
The over-arching goal of this proposal is to establish the predictive multi-scale mathematical model to decipher the
mechanism of durotaxis. Durotaxis is the preference of cells migrating toward a stiffer extracellular matrix (ECM) and has
important roles in many biological processes, ranging from embryo development to tumor metastasis. Focal adhesion (FA)
is the functional unit of durotaxis; it an integrin-based multi-protein transmembrane linkage, through which cell exerts actin
cytoskeleton-based traction force to tug the ECM and sense the stiffness. Despite the high relevance to biomedical
applications, it is not well understood how FA mediates mechanosensing of ECM stiffness and drives durotaxis, largely
because predictive mathematical models lag behind the descriptive experimental finding in the field. At single-FA level,
while previous models explain molecular-clutch behaviors in FA mechanosensing, they cannot explain how and why FA-
localized protein activities adapt to environments by distinctive spatial-temporal patterns (akin to footprints) that are
demonstrated to be essential for durotaxis. The full underlying mechanisms of the FA-localized “footprint” and its exact
roles in durotaxis are thus unknown. Further, durotaxis must coordinate movements of cell body and protrusion/retraction
of cell edge. While the FA-mediated tractions drive the cell body, how the FA-localized mechanosensing events coordinate
with the cell edge dynamics is unknown. Last, at a single-cell level, there exist many FAs at different developmental stages
at any time. It is not understood how the cell integrates the mechanosensing activities of individual FAs to drive durotaxis.
A predictive model that meaningfully engages with experiments is desirable and likely holds the key to decipher
durotaxis. Toward this goal, we have been and will uniquely integrate mathematical modeling in iterative dialogues with
experimental testing. The central hypothesis is: FA-localized spatial-temporal dynamics of the traction force generation and
transmission defines FA-mediated mechanosensing and durotaxis. The basis of this proposal is our previous findings. We
built the first mathematical model that captures the essence of entire FA maturation process. That is, FA evolves from a
nascent complex, the centripetally growing FA that couples the retrograde flux of branching actin network, to the mature
FA that transmits the stress fiber (SF)-mediated contractions onto ECM. This model uniquely links the FA-localized fine
features of protein activities – emerging from FA maturation process – to FA mechanosensing events. The model predicted
and was experimentally confirmed that a negative feedback between the elongation and contractility of the FA-engaging SF
underlies the FA-localized traction oscillation and mechanosensing of ECM stiffness. Ushered by these findings, our
specific aims are to determine: 1) how FA force-transmission and SF elongation cross-talk in FA mechanosensing; 2) how
FA mechanosensing affects cell edge protrusion/retraction, and 3) how cell integrates mechanosensation of individual FAs
to drive durotaxis. If successful, the proposed research would provide a quantitative platform interpret data and guide
durotaxis experimental designs, which has the multi-scale resolutions ranging from FA-localized dynamics, cell edge
protrusion/retraction, to cell movement at whole-cell level.

Public health relevance
Project Narrative The preference of cell migration toward a stiffer substrate (termed “durotaxis”) is important for many biological processes, ranging from embryo development to tumor metastasis; however, its underlying mechanisms remain elusive, largely due to its multiplex nature and that predictive mathematical models lag behind the descriptive experimental finding. While it is well documented that focal adhesion (FA), an integrin-based multi-protein transmembrane linkage, defines the functional unit of durotaxis and adapts distinctive FA-localized spatial-temporal dynamics to substrate mechanics, it is not understood how FA mediates the mechanosensing of substrate stiffness and drives durotaxis. By iterative model-experiment dialogues, we aim to provide the first predictive multi-scale mathematical model to decipher the mechanisms of durotaxis, beginning with molecular mechanisms of FA-mediated mechanosensing, to crosstalk between FA and cell edge protrusion/retraction, all the way to the durotaxis at a whole-cell level.